CST6-mRNA activated matrices for efficient bone regeneration

Project Summary
Bone regeneration is a carefully orchestrated dynamic process that involves several key
biological players, including growth factors and cells. Bone tissue engineering aims to
provide an environment that facilitates and augments the natural bone regeneration
process. CST6 is a cysteine protease inhibitor that is highly expressed in multiple
myeloma patient samples lacking any bone lytic lesion, compared to those samples with
at least one bone lytic lesion. In vitro pilot studies show that CST6 (in the recombinant
protein form) promotes osteoblast differentiation and inhibit osteoclast differentiation.
CmRNA has the unique advantage of functioning entirely in the cytoplasm (avoiding the
need for nuclear entry) thereby, leading to a targeted transient expression of desired
proteins with immense potential to overcome the challenges that exist with protein and
DNA based approaches. Specifically, this study aims to develop a biomaterial-based
delivery system that releases cmRNA (CST6) to induce in vivo bone regeneration. Our
aims are 1) to demonstrate that nanoparticle loaded cmRNA (CST6) can efficiently
trigger osteogenic differentiation and inhibit osteoclast maturation and 2) to assess bone
regeneration efficacy of a collagen scaffold that delivers cmRNA (CST6) in unilateral
diaphyseal femoral defects in rats

Public health relevance
Project Narrative In medicine and dentistry, there is an enormous need for cost-effective and predictable tissue regeneration strategies. The results of this proposed study will provide critical information on the safety and effectiveness of chemically modified RNA of CST6, a novel active agent to enhance bone regeneration. New knowledge gained from the proposed study will facilitate our long-term goal of translating this therapeutic strategy into the clinic.